COMPUTER ANALYSIS OF HUMAN GENOME USING THE WISCONSIN PACKAGE

Our lab studies the molecular biology of blood clotting proteins and the genetics of the associated human diseases. Our current work focuses on structure/function analysis of plasminogen activator inhibitor-1 and von Willebrand's factor, as well as the genetics of von Willebrand's disease.